The Allee Effect in Tumor Initiation

SUMMARY

In ecosystem modeling, the Allee effect describes a correlation between population size (number of members)
and mean fitness (proliferation rate) of individuals. Increased proliferation with increased population size
implies cooperative interactions. A contrasting principle in ecosystems is population “carrying capacity” which
describes a decrease in growth rates with increasing population size, due to competition for limited resources.
While the concept of carrying capacity has been studied in tumors (which may become limited in nutrients or
oxygen), the Allee effect has been almost entirely overlooked. Allee effects are significant in small populations
and thus may be critical to understanding the earliest steps in tumor iniation. To investigate the fundamental
contribution of the Allee effect on tumor ecosystems requires the novel experimental designs and integration of
quantitative experimental measurements with mathematical modeling. The overall goal of this project is to
dissect the contribution of population size and cell-­cell communication in a few selected, well-­suited tumor cell
lines through quantitative single-­cell resolution, real-­time monitoring of cell populations. Mathematical models
of growth kinetics will show that the Allee effect and cell-­cell communication has consequences on a single
cancer cell’s decision to initiate a growing tumor or to stay dormant. These communication networks will be
further mapped by identification of specific paracrine factors and receptors. Disruption of the communication
network that establishes a proliferative tumor will be performed by targeting specific cell subpopulation
interactions. Perturbations will include depletion of specific cell subtypes, manipulation of overall paracrine
signaling, and blocking of specific ligand-­receptor combinations on interacting species. These strategies may
be novel tools to trigger tumor cell population collapse. Population-­level effects in a nascent tumor population
have not been quantitatively explored and may explain the phenomenon of critical thresholds and define a
mechanistic role for intratumor heterogeneity. This project focuses on a fundamental generic principle that is
broadly applicable in many contexts and thus could complement and enrich the modeling efforts of the cancer
research community.

Public health relevance
Narrative With aging, individuals accumulate numerous microscopic lesions in the breast, prostate, thyroid and other tissues;; the majority of these microscopic lesions do not progress to invasive tumors. Here we investigate the transition at tumor initiation with the goal of understanding how to prevent early lesions from undergoing proliferative growth. We study the role of tumor cell heterogeneity in controlling the transition from indolent microlesions to invasive tumors.